Systematic Assessment of Combinatorial Transcription Factor Activity

PROJECT SUMMARY
Despite vast catalogs of transcriptomes, our understanding of transcriptional state remains mostly descriptive.
In this proposal, we seek to advance the field towards a predictive understanding of cell state by addressing the
fundamental gap in knowledge: what are the genes and regulatory networks that drive a cell’s transcriptional
state? This knowledge will be critical to understand the molecular basis of cell state and to manipulate cell state
for biomedical applications. Transcription factors (TFs) cooperatively drive gene regulatory networks (GRNs) to
establish transcriptional states. Notably, forced induction of TFs can reprogram gene expression states by sup-
planting existing GRNs. Thus, TFs and GRNs are the building blocks to a predictive understanding of a cell’s
transcriptional state. One key challenge is that, in general, the relationship between TFs and GRNs is not known
and is difficult to accurately predict. This challenge arises from several current problems: a lack of ground truth
GRNs derived from experimental TF perturbation, a reliance on static transcriptomic databases to infer GRNs
for TF cocktail prediction, and the difficulty of predicting non-linear TF behaviors. Until we can understand how
TFs cooperatively influence GRNs, our ability to predict the TF drivers of cell state will remain limited. Our long-
term goal is to understand the molecular basis of transcriptional state for applications in cellular engineering.
Towards this goal, the objective of this proposal is to generate a unique resource to directly measure GRNs for
simple combinations of TFs, and to use this functional knowledgebase to predict and benchmark complex TF
cocktails for transcriptional reprogramming. We hypothesize that experimentally-derived GRNs will improve the
performance of predicted TF cocktails for transcriptional reprogramming. Our rationale is that these studies will
1) provide a novel and urgently needed resource of TF functional activity and experimentally-derived GRNs for
the community, 2) provide insights into the molecular drivers of transcriptional state, and 3) identify TFs with
potential to engineer gene expression states for biomedical research. We propose the following specific aims:
(Aim 1) Measure the combinatorial activities of transcription factors; (Aim 2) Improve computational frameworks
to predict TF cocktails for transcriptional reprogramming; (Aim 3) Generalize TF-driven GRNs across initial cell
contexts and benchmark predictions. This proposal is innovative because it will use our single-cell platform Re-
program-Seq 2.0 for high-throughput transcriptional reprogramming to generate a unique resource of functional
activities for TFs and GRNs. We expect this resource to propel new research horizons. This proposal is signifi-
cant because it will expand our understanding of genome function by quantifying combinatorial TF activity, ex-
perimentally deriving GRNs, and providing new tools to engineer gene expression states.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because understanding the molecular basis of transcriptional state is ultimately expected to advance the capability to alter and engineer cell states for biomedical applications. The project is relevant to the part of NIH’s mission to accelerate the understanding of how genomes function and to use this fundamental knowledge to ultimately improve human health.